Characterizing accuracy and variability in speech sound productions across bidialectal and bilingual preschoolers

Project Summary/Abstract
Speech sound disorder (SSD) is a high-incidence developmental disability that can result in long-term negative
impacts on academic and career achievement. Although the impacts of SSD can be mitigated through
evidence-based interventions, the challenge of diagnosing and managing SSD is greatly exacerbated when
working with clients from linguistically diverse backgrounds. A clinician evaluating a child who uses more than
one language daily must avoid over-diagnosing disorder in cases more accurately characterized as differences
while also guarding against under-diagnosis of SSD in this population. This need to reduce misdiagnosis of
SSD is particularly pressing in understudied contexts, namely children who are bidialectal or bilingual in two
closely related languages. In these cases, production variation is ubiquitous yet might be flagged as being
atypical in the diagnostic process. Languages interact differently depending on their typological properties, and
the body of existing literature focused on a small set of relatively well-documented cases (e.g., Spanish-
English) runs the risk of arriving at an overly homogenous model of speech development and disorders. By
studying two groups of children – those acquiring African American English and Standardized American
English (AAE/SAE) and those acquiring Jamaican Creole and Jamaican English (JC/JE) – this proposal not
only benefits underserved populations but will also broaden the theoretical base for understanding speech
development and disorders in linguistically diverse contexts. Although our team has made recent strides
toward understanding trade-offs between accuracy and variability in a bilingual context, additional elaboration
of the theoretical framing is needed to inform the diagnostic significance of production variation when
languages are linguistically related. We propose to model the relationship between accuracy and variability in
production using the Articulatory Map ([A-map]; McAllister Byun et al., 2016) and Gradual Learning Algorithm
([GLA] Boersma and Hayes, 2001). Application of the A-map and GLA are needed to account for typological
patterns of phonetic and phonological learning across language contexts both theoretically (A-map) and
computationally (GLA). The long-term goal of this research is to arrive at a coherent understanding of
production variation to reduce misdiagnosis of SSD in underrepresented populations. Using transcription-
based measures of accuracy and acoustic (spectral)-based measures of variability, we will test the predictions
of the A-map and GLA in preschool-aged bidialectal AAE/SAE and bilingual JC/JE speakers. Statistical
modeling of the relative contributions of acoustic-based measures of variability and transcription-based
measures of accuracy to a gold standard diagnosis will be used to identify the optimal diagnostic criteria for
disorder status. The data we generate will support a methodological template for protocols that reduce
misdiagnosis of SSD in bidialectal and bilingual children to meet the NIDCD 2023-2027 Strategic Objective
Theme 4: Goal 3 to advance understandings about communication disorders in underrepresented populations.

Public health relevance
Project Narrative Bidialectal and bilingual children are routinely misdiagnosed for speech sound disorder, with under-diagnosis having lifelong negative impacts on academic and career achievement and over-diagnosis putting the child at risk for social stigma while posing an unnecessary cost to the school system. By targeting under-studied language combinations (African American English-Standardized American English bidialectals; Jamaican Creole-Jamaican English bilinguals), this research will broaden the theoretical and empirical knowledge base that guides clinical management of speech development and disorders in bidialectal and bilingual children. Using a combination of transcription-based measures of accuracy and spectral acoustic-based measures of variability, we will compare typical development across bidialectal and bilingual speakers and identify the factors that most accurately separate typical and disordered speech development in these understudied populations.